Leadership, Planning and Evaluation

LEADERSHIP, PLANNING AND EVALUATION – PROJECT SUMMARY/ABSTRACT
The Cold Spring Harbor Laboratory (CSHL) Cancer Center is led by Director David Tuveson (Cellular
Communication in Cancer Program). Tuveson succeeded former Cancer Center Director Bruce Stillman as the
Director of the Cancer Center in 2016. As Director, Tuveson is responsible for the overall direction, planning,
and allocation of Cancer Center Developmental and discretionary funds to support his vision for the CSHL
Cancer Center, including support of cancer research and the Shared Resources. He is assisted by four Deputy
Directors: Adrian Krainer (Gene Regulation and Inheritance Program), Nicholas Tonks (Cellular
Communication in Cancer Program), Lloyd Trotman (Cellular Communication in Cancer Program), and Denise
Roberts (Administration). Krainer, Deputy Director of Programs, is primarily responsible for oversight of Cancer
Center Programs to ensure they align with the strategic vision for the Cancer Center, and for determining the
cancer relevance of members’ grants. Tonks, Deputy Director of Operations, is primarily responsible for oversight
of the Shared Resources to ensure they maintain exceptional services and scientific support. Trotman, Deputy
Director of Education and Diversity, oversees Cancer Center educational initiatives, advises in Cancer Center
recruitment, and coordinates Cancer Center educational initiatives with those of the T32 Cancer Training Grant.
Roberts, Deputy Director of Administration, coordinates all administrative services on behalf of the Cancer
Center and aids Tonks in the management of Shared Resources. Tuveson has instituted several changes to the
CSHL Cancer Center, including the appointment of new Leadership, reorganization and rebranding of Cancer
Center Programs, recruitment of new members, establishing new Share Resources, launching of new
educational initiatives, and strengthening the alliance between the Cancer Center and Northwell Health to
promote translational research. Planning and evaluation are critical to ensure the Cancer Center maintains its
highly innovative research and first-rate Shared Resources. With the help of Cancer Center Senior Leadership
and the Cancer Center Executive Committee, the Director has developed a clear, yet flexible, vision for the
coming grant cycle. Advice from both internal and external committees, including the External Advisory Board,
is used by the Cancer Center Leadership to evaluate plans and ensure that strategic initiatives are well designed
and effectively implemented. The CSHL Cancer Center Leadership are committed to maintaining and continually
improving the Cancer Center to ensure its position as a premiere institute for basic cancer research.

Public health relevance
LEADERSHIP, PLANNING AND EVALUATION- PROJECT NARRATIVE Not required per PAR-20-043